ALCOHOL RESEARCH UTILIZATION SYSTEM (ARUS)

The purpose of this contract is to procure support services for managing the logistic activities of the Alcohol Research Utilization System (ARUS) which will include arranging for convenient and cost-effective meeting facilities, travel, lodging, meals, honoraria and other details such as mailing proceedings, distributing summary proceedings of meetings and workshops, and preparing video tapes.